Research and Development to Establish a Small Animal Model as a Significant Resource of High-Value Single-Domain Antibodies

Project Summary
Genetically-modified mouse models have proven to be essential for the production of antibody-related
biological drugs (biologics). To date, the majority of biologics originate from mouse models, and small animal
models are used not only to generate the antibodies, but also as a platform for further optimization and testing
of the biologics. Camelid-based antibodies, which have superior antigen binding and physicochemical
properties (stability, hydrophilicity, etc.) have not realized their full potential, to the same extent that
conventional antibodies have. This is founded in the logistic and financial hurdles immunization of camelids
pose for monoclonal heavy-chain antibody (HCAb) production and the fact that in vitro technologies cannot
fully recapitulate the exceptional natural selection towards extremely diversified, high-affinity binders that
occurs in animals. In this SBIR project we propose to develop genetic platforms in a murine host for the
discovery and development of partially humanized hybrid HCAbs (and their products). Since their discovery in
the early 1990s, HCAbs have generated progressive interest in the biotech, diagnostic and therapeutic fields
due to their intrinsic properties and adaptability. Apart from a small size paired with robustness and superior
access to difficult epitopes, HCAbs can be easily processed into, and utilized as, single domain binding units
(VHH) while preserving their affinity towards antigens (in contrast to conventional antibodies). The proposed
targeted mouse models carrying an engineered immunoglobulin locus will potentiate the production of high
affinity HCAbs by serving as an alternative, hybrid Ab host. It will allow natural, in vivo affinity-maturation of
antigen-specific HCAbs in a small animal platform, one amenable to further genetic manipulation. It will enable
larger cohort sizes than the natural camelid hosts, and streamline HCAb generation, thus providing further
potential for the development of HCAb and VHH domains for downstream applications. In our Aim 1, we focus
on honing and characterizing our hybrid camelid immunoglobulin locus by adding more camelid VHHs and
introducing modified human VHs into the locus while also evaluating B-cell development and antibody affininty
and diversity. In Aim 2, our focus is to benchmark the the repertoire and efficiency of the Ab response with
competing technologies by using disease-relevant, difficult antigens and progress promising hits to hybridoma
development and larger scale antibody production. In accomplishing these milestone based Aims, we will be
able to develop our business and begin licensing of the platforms to individual labs and established
pharmaceutical companies to support discovery of novel antibodies for high-value targets.

Public health relevance
Narrative Antibodies, the pathogen-neutralizing proteins produced by the immune cells, are critical for the humoral immune response against bacteria and viruses and play a critical role in the immune responses to cancer. The unconventional single-chain antibodies from camelid species have unique target-binding properties and have greatly increased in vivo stability compared to conventional antibodies – properties that make them highly attractive for therapeutic and diagnostic applications. We propose to generate genetically-engineered mouse models that will allow in vivo production of partially humanized single-chain antibodies that resemble those from camel species, thus establishing a platform for the generation, optimization and testing of these unique antibodies for downstream therapeutic applications.